Neutrophil-driven mucosal dysfunction in SIV/malaria co-infection

PROJECT SUMMARY/ABSTRACT
With more than 37 million people living with HIV (PLWH) and an additional 1.7 million new infections per year,
HIV remains one of the world’s most devastating diseases. Moreover, in 2018, infection with malaria was
reported to have reached 228 million cases worldwide and to have caused over 405,000 deaths. Although
advances have been made in reducing the incidence of both HIV and malaria, the risk of infection with either
disease is still great, especially in resource-limited countries. Importantly, as HIV and malaria are endemic to
similar areas, the geographical overlap constitutes a great risk for co-infection, fueling the transmission and
pathogenesis of both diseases. HIV and malaria have each been shown to cause gastrointestinal (GI)
pathologies, including disruption of the epithelial barrier and elevated microbial translocation. These disease
characteristics are highly associated with risk of morbidity and mortality; however, the underlying biological
mechanisms by which they occur remain unclear. Previous work suggested that inflammatory neutrophils
accumulate, are hyperactivated, and have prolonged survival capabilities in the GI tract during SIV/HIV infection.
Additionally, prior studies demonstrated that alterations in neutrophil function associates with malaria
pathogenesis. However, the role of neutrophils in mucosal dysfunction and risk for morbidity and mortality in the
context of HIV/malaria co-infection has not been established. Our global hypothesis is that malaria co-infection
of SIV-infected rhesus macaques will result in increased neutrophil accumulation and hyperactivity in the GI
tract, which will lead to elevated immune activation, epithelial barrier dysfunction and microbial translocation. In
the proposed project, we aim to longitudinally assess neutrophil kinetics and function throughout malaria infection
of SIV-infected rhesus macaques. Additionally, we will characterize the role of neutrophils in exacerbated
mucosal immune activation, barrier integrity, and microbial translocation in SIV/malaria co-infected macaques.
Finally, we will utilize in vitro co-culture systems to investigate the use of neutrophil targeting strategies to limit
inflammatory responses and restore barrier integrity. In sum, these studies will generate critical knowledge of
the impact of malaria co-infection on SIV-associated immune dysfunction. Moreover, these experiments will lay
the groundwork for future pre-clinical and clinical studies targeting neutrophils to reduce intestinal inflammation
and restore mucosal homeostasis. Ultimately, the successful completion of this project will propel the
development of more effective therapies for use in resource-limited settings, where the burden of HIV and malaria
are greatest.

Public health relevance
PROJECT NARRATIVE Novel strategies to reduce the risk of morbidity and mortality due to HIV, malaria, and HIV/malaria co-infection are urgently needed. Intestinal mucosal dysfunction has been associated with pathogenesis in both HIV and malaria; however, the precise biological mechanisms of immune disruptions during co-infection remain unclear. This innovative study will examine neutrophils as an underexplored disease mechanism and possible therapeutic target to reduce mucosal dysfunction and restore homeostasis in HIV and malaria infection, with the ultimate goal of lessening the substantial public health and economic burden caused by these pathogens.